NICHD maternal fetal medicine units network

ABSTRACT
This proposal describes the application of The Ohio State University (OSU) Center for continued participation
in the Eunice Kennedy Shriver NICHD Maternal Fetal Medicine Units (MFMU) Network. The current application
describes our team, environment and resources to meet the objectives of the Network. Since 1992, the OSU
Center has demonstrated a strong performance and experience in conducting clinical and translational
research based on excellent infrastructure and institutional support. We developed a strong research team led
by Maged Costantine, MD who was recruited to the OSU Wexner Medical Center in 2019, as a Division
Director for Maternal Fetal Medicine and Principal Investigator for the MFMU Network Center, and Mark
Landon, MD who serves as Chair for the Department of OG/GYN and Alternate PI. In addition to productivity in
the MFMU Network, both the PI and alternate PI, bring extensive experience in study design, recruitment, data
analysis, and publications. The OSU Network will recruit study participants from diverse populations at 3
medical centers with a combined total of more than 15,000 annual births, many of them are high-risk, and the
majority receiving prenatal care at the three systems. Our Center Nurse Coordinator, Anna Bartholomew,
MPH, RN, BSN, CCRP, leads a large group of faculty & research staff capable of recruiting and retaining
patients in the setting of an excellent research organization enhanced by 29 years of experience in the MFMU
Network, participation in the NICHD Nulliparous Network, and memberships in the North American Fetal
Treatment Network, and Ohio Perinatal Research Network (OPRN). We benefit from a robust bioinformatics
structure and versatile Electronic Medical Record System (EMR) that captures antepartum, intrapartum, and
postpartum data online and is readily available to authorized research personnel for query as well as automatic
notification, an extraordinary group of obstetrical sonographers, perinatal epidemiologists, and a mature
research infrastructure supported by a CTSA grant shared with Nationwide Children’s Hospital. Our satellite
sites, Miami Valley Hospital in Dayton and Good Samaritan Hospital in Cincinnati, have an outstanding record
of recruitment in the most recent Network cycle, well-established research culture, and ambitious goals for
MFMU Network participation. Our partnership and strong collaboration with Neonatology at Nationwide
Children’s Hospital in clinical care and research, Pathology and Clinical Laboratory add strengths to our
application. We look forward to continuing our tradition of service, strong performance, and innovation in the
next cycle of the NICHD MFMU Network. We accept the RFA’s capitation and participatory stipulations and
stand ready to achieve the goals of the Network in completion of the ongoing studies in a collaborative way
across all research centers.

Public health relevance
NARRATIVE The NICHD MFMU Network is the premier obstetric research network in the world. Clinical investigations of the causes of perinatal and infant mortality and morbidity and their ultimate prevention require large and diverse numbers of participants that are best recruited from multiple collaborating centers. The Ohio State University Center has been a leading member of the MFMU Network since 1992 and has an energized research team commit to build upon our tradition of excellence to achieve the goals of the Network in completion of the ongoing studies in a collaborative way across all Network centers.